Evaluating Effectiveness and Implementation of a Risk Model for Suicide Prevention Across Health Systems

PROJECT SUMMARY/ABSTRACT: Despite decades of prevention research, suicide remains a
persistent public health problem in the United States. In the last decade, rates of suicide death increased
among both males and females, and across age groups between 15 and 44. However, arguments for
universal suicide risk screening are weakened by the pragmatic realities of suicide prevention in health
systems, the rarity of suicide mortality, and the lack of 1) association between suicide ideation and near-term
risk of suicide mortality, 2) evidence for risk stratification based on suicide ideation, and 3) screening
instruments validated for suicide mortality. Risk identification models using electronic health records (EHR)
data have demonstrated superior accuracy compared to traditional clinical assessment or self-reported
screening measures. Yet, use of these models in clinical settings outside of the Veterans Administration has
not been evaluated. Our ongoing clinical trial, “Evaluating Effectiveness and Implementation of a Risk Model
for Suicide Prevention Across Health Systems” (R01 MH130548), is designed to test the ability of a suicide
risk identification model to reduce suicide attempts in real-world settings that represent typical care. The
clinical trial is limited to adults receiving behavioral health services; this is the population our clinical partners
(three large health care delivery systems) were interested in testing first. However, all of these systems
acknowledged interest in spreading the model to youth and to primary care or other settings. In this
competitive revision application, we propose to collect additional data to evaluate the effect of the model on
an adolescent population that is currently receiving the suicide risk identification model intervention but not
being evaluated as part of the original study, and to describe characteristics of other at-risk groups who do
not receive any intervention in the original study (e.g., patients insured by but receiving behavioral health
outside one of these health systems, those presenting in primary care, those not presenting for care, and
patients at varying risk thresholds lower than those set within the study). Studying these other groups will
help to prepare for broader scale implementation within and beyond the health systems participating in the
trial. Based on previous experiences, if the clinical trial shows that the risk model reduces suicide attempts,
we expect our delivery system partners will eagerly proceed with broader implementation ahead of evidence
justifying its use in these other populations. Therefore, it is urgent that we leverage the opportunities
provided in the original study to learn what we can to inform next steps and to help new adopters considering
these implementation decisions. The proposed competitive revision is innovative in that it will be the first
study to evaluate the impact of a suicide risk identification model in an adolescent sample. It also offers the
opportunity to study potential primary-care-based and outreach-based approaches in a non-Veteran sample.

Public health relevance
PROJECT NARRATIVE Clinical interest in suicide risk identification models as tools to more accurately identify patients at risk for suicide is high. A hybrid effectiveness/implementation trial is currently underway but pragmatic decisions made during implementation have left gaps in the potential knowledge to be gained from the trial. This supplement will allow analysis of outcomes for an adolescent population, and the opportunity to characterize the population that is currently being missed during the ongoing trial due to health system implementation decisions to focus only on patients who present for behavioral health visits.